A Novel Antibody that Promotes Neuronal Integrity and Neurogenesis for Treating Alzheimer's Disease

Project Summary
Our goal is to develop a novel neuron-penetrating bispecific antibody that promotes neuronal integrity and
neurogenesis for the treatment of AD. In the US alone, over 6 million Americans are currently living with AD,
with total economic costs around $355 billion in 20211. Despite the staggering cost, only a few mildly effective
AD symptom-treating drugs exist. As a result, treating and even reversing the effects of AD remains a
significant unmet need.
Pathologically, AD is characterized by the presence of neuritic plaques and neurofibrillary tangles in the brain.
The primary component of the extracellular neuritic plaques is the β-amyloid protein (Aβ), an approximately 4
kDa fragment proteolytically derived from the larger amyloid precursor protein (APP)2. A vast amount of
literature has implicated Aβ accumulation as being central to the progression of AD, and inhibiting Aβ
production represents a promising strategy for treating AD.
We have generated two single-chain variable domain antibody fragments (scFv), Asec and Bsec, which
respectively promote α-secretase activity and block β-secretase activity toward amyloid precursor protein
(APP) by binding to APP at either the α-site or the β-site3-5. Next, we generated a tandem bispecific antibody
that combines the Asec and Bsec scFvs and showed that it elevates levels of sAPPα, a soluble α-secretase-
associated APP fragment, and decreases levels of Aβ and sAPPβ, a soluble β-secretase-associated fragment
in cell models of AD6. An ApoB tag was added to the bispecific antibody (called VTC-939), which can facilitate
transfer across the blood-brain barrier (BBB)6-8 and neuronal targeting. Using recombinant human adeno-
associated virus (rAAV) as a vector infective to hepatic cells, VTC-939 could be secreted into the blood and
brain at high levels. When VTC-939 was tested as a therapeutic in an APP/PS1 AD mouse model, VTC-939
increased levels of sAPPα, while decreasing Aβ deposits and oligomeric Aβ levels. In addition, VTC-939
treatment increased neuronal health, substantially increased hippocampal neurogenesis and significantly
increased survival rates compared with untreated mice9. These results indicate that altering APP processing to
inhibit toxic amyloidogenic β-site activity while simultaneously promoting neuroprotective α-secretase
processing provides increased neuronal benefits and represents a promising new therapeutic approach for
treating, and potentially reversing AD.
Building from this work, our objective is to develop VTC-939 as a novel neuron-penetrating antibody that
restores neuronal integrity and promotes neurogenesis for the treatment of AD. The specific aims are to: 1)
produce antibody constructs and establish quality control assays, 2) determine the optimal effective dose of
VTC-939 to promote neuronal integrity, neurogenesis and longevity in the APP/PS1 AD mouse model, and 3)
generate acute toxicology and biodistribution profiles for VTC-939 in normal healthy mice. A therapy that can
safely and effectively promote neuronal integrity and neurogenesis would provide a significant advancement
for a clear unmet medical need.

Public health relevance
Project Narrative In the US alone, over 6 million Americans are currently living with Alzheimer’s disease (AD), with total economic costs around $355 billion in 20211. This project is focused on developing a novel neuron-penetrating bispecific antibody that restores neuronal integrity and promotes neurogenesis in an AD mouse model. A therapeutic that can effectively and safely promote neuronal integrity and neurogenesis while preventing AD disease would provide a significant advancement for a clear unmet medical need.